Development of a Mobile Health Intervention for Blood Pressure Management in Pregnancy

ABSTRACT
Hypertension in pregnancy is highly prevalent and increasing in the United States, and 40% of maternal deaths
involve women with hypertension. In adults from racial/ethnic minority groups, hypertension is two-fold more
prevalent and leads to higher rates of preeclampsia and stroke, thus resulting in devastating health
consequences in the infant and mother alike. The time required for frequent in-person visits, inadequate
counseling, and the asymptomatic nature of hypertension are major barriers to effective blood pressure (BP)
control in pregnant women. These issues can be addressed through home BP monitoring (HBPM), which holds
the potential to reduce preventable and devastating clinical events while also proven to reduce racial inequities
in pregnant women. Obstetric societies recommend HBPM for all pregnant women with hypertension, but
our pilot work suggests that rates of HBPM counseling and uptake are low. With the increasing use of mobile
health apps in pregnancy, there is an opportunity for digital health approaches with culturally appropriate
storytelling to improve HBPM and allow pregnant women with hypertension to learn from others with similar
lived experiences.
We are requesting an administrative supplement to allow for direct caregiving for critical illness, to support the
aims of the parent K23 Award proposal to develop Moms@Home, a digital health approach to support HBPM
in pregnant women with hypertension. Moms@Home integrates storytelling videos with a Social Cognitive
Theory-based proven approach to support behavior change and address the cultural and literacy needs of a
diverse population of pregnant women. We hypothesize that incorporating storytelling with a successful
digital health approach may increase the adoption of HBPM. Aim 1 has adapted the existing mobile health
app MyDataHelpsTM to create Moms@Home for pregnant women with hypertension by incorporating stories from
women with similar lived experiences. Aim 2 has led to refinement of the Moms@Home components with
obstetric caregiver and patient interviews. Aim 3 will pilot test the Moms@Home approach in pregnant women
with hypertension, enriched in those from racial/ethnic minority groups, to assess HBPM adherence, feasibility,
and acceptability.
Beyond the research plan, the K23 will provide Dr. Kovell with advanced research training, protected time, and
mentoring to become an independent physician-scientist focused on improving outcomes for pregnant women
with hypertension. This K23 award, with additional support from the administrative supplement, will set the
stage for Dr. Kovell’s future R01 application examining digital behavioral health interventions on BP control
for pregnant women with hypertension. This innovative and scalable proposal has tremendous potential to
positively impact and support women with hypertension through healthy pregnancies.

Public health relevance
PROJECT NARRATIVE The U.S. has the highest rate of maternal mortality among high-income countries and hypertension is a leading cause, contributing to 40% of maternal deaths. To improve the quality, peer support, and cultural relevance of hypertension care, this administrative supplement will examine the effects of the digital health approach Moms@Home on home blood pressure monitoring in pregnant women with hypertension. By facilitating more timely diagnosis and potentially better blood pressure control with digital health and home blood pressure monitoring, this proposal holds promise to reduce the risk of preventable and devastating clinical events for women with high-risk pregnancies and their children.